MITOCHONDRIAL DNA REPAIR PROCESSES IN OXIDATIVE STRESS AND AGING

Summary of work: Based upon our previous finding that there is an increase with age in the activity of a mitochondrial DNA glycosylase/endonuclease (mtODE) which is specific for 8-OH deoxyguanosine (8-OHdG), we have hypothesized that there is an induction of this enzyme of DNA repair in response to chronic oxidative stress. This project tests this hypothesis. Rats were subjected to regimens described as causing oxidative damage to liver mitochondrial DNA (mt-DNA) and mitochondrial extracts were tested for activity in the incision of oligonucleotides containing a single 8-OHdG. Treatment with AZT for 6 weeks elicited no increase in mt-ODE activity, but also gave no increase in TBARS (a product of lipid peroxidation) or in superoxide dismutase (SOD) activity. Provision of 8% ethanol as the sole source of drinking water for periods of 6 weeks or 15 weeks, a procedure which has been reported to raise liver mt-DNA 8-OHdG content, also gave no change in mt-ODE activity relative to controls. Again, there was no change in TBARS or SOD activity, questioning the severity of the oxidative insult. Thus the role of oxidative stress in the induction of this enzyme activity remains to be resolved. However, we have extended and strengthened our original finding of an increase in mt-ODE activity with aging. In liver mitochondrial extracts, there was a highly significant increase in activity between 6 months and 23 months of age, with the activity being at a maximum at an intermediate age (12 months). The same pattern was seen in extracts of heart mitochondria. By contrast, two other mitochondrial enzymes of DNA metabolism which are not specifically involved in the repair of oxidative damage, viz. uracil DNA glycosylase (mtUDG) and AP endonuclease, were found to be either unchanged or minimally changed with aging. This increase in mitochondrial DNA repair with aging is also seen in mice of different ages. It is suprising and may stimulate new directions as it was previously thought that DNA repair capacity declined with age. Recent experiments have used primary cultures of hepatocytes from young and old rats. We have developed new techniques to measure DNA repair in mitochondria. Using cell extracts, incision and incorporation of damaged DNA can be detected, and we can thus now approach the studies on the changes with aging more mechanistically. - DNA glycosylase/endonuclease 8-hydroxydeoxyguanosine HPLC/EC alcohol